Establishing sensory functions of pharyngeal enteric neurons in C. elegans

SUMMARY
Interoception is a critically important process that allows animals to sense internal signals in
order to appropriately regulate their behavior and physiology. Here we propose to address the
fundamental question of how organisms sense and regulate these internal signals, focusing on
the enteric neurons of the foregut (“pharynx”) of the nematode C. elegans as a model system.
Across animal phylogeny, enteric nervous systems are autonomously acting circuits that are
essential for integrating a diverse set of multimodal internal sensory cues and relaying them to
other parts of the organism. Dysfunction of these processes results in systemic metabolic and
physiological disorders including disorders of gut motility and function, as well as neurological
and neuropsychiatric syndromes. However, despite the essential role of the enteric circuit, the
cellular and molecular mechanisms by which enteric neurons detect and respond to internal
cues are poorly understood. Here we bring together the complementary expertise of our labs to
study the molecular and circuit mechanisms of three different sensory modalities that we have
shown to be perceived by enteric neurons: a high salt-sensing sensory phenomenon, the
sensation of a putative bacterial metabolite, and an internal proprioceptive sensory process that
relates to the peristaltic movement of the foregut. For each of these sensory processes, we
have identified a diverse set of conserved putative sensory receptors expressed in highly
restricted sets of enteric neurons, and found that their disruption leads to defects in feeding
behavior and physiological adaptation. The specific goals of this proposal are to investigate the
localization, functions, and downstream signaling events that allow these molecules and enteric
neurons to detect chemical and mechanical cues, and transmit these signals to alter behavior.
Chemosensation and mechanosensation are conserved properties of enteric neurons in
vertebrates including in humans. Thus, results from this proposed work will provide new insights
into the mechanisms by which enteric neurons sense and relay information to maintain and
modulate physiological homeostasis across species.

Public health relevance
PROJECT NARRATIVE Enteric neurons of the gut play important roles in sensing internal cues such as ingested chemicals and mechanical stimuli, and in turn, regulate gut motility, digestive processes, and gut-brain interactions. We will investigate how enteric neurons of the foregut in the nematode C. elegans detect diverse sensory stimuli and regulate feeding behavior and physiology. We expect that findings from this work will provide new information about the conserved functions of the enteric nervous system across species.